Neuronal Activity-Induced IEG Transcription Factors in Neurodevelopment and Plasticity

Project Summary:
Neural circuits are continually shaped and reshaped during development and throughout life in response to
ongoing experience. In addition to short-term changes in synaptic strength, sensory-driven neuronal activity
drives long-lasting circuit adaptations that are critical for learning, memory, and behavior, but the mechanisms
that underlie these long-lasting changes in neural circuitry have been challenging to discern. We discovered that
neuronal activity induces gene programs that mediate various aspects of synaptic development, including
dendritic outgrowth, spine and synapse maturation, synaptic pruning, myelination, and excitatory/inhibitory
balance. And we demonstrated that these gene networks are required for learning, memory, and behavior in
mice, and have linked these gene programs to multiple neurodevelopmental disorders in humans. These findings
underscore the critical role these gene networks play in human cognitive development and function. While highly
context- and cell-type-specific, neuronal activity-dependent gene responses exhibit a standard architecture in
which neurotransmitter release at synapses drives the transcription of a largely common set of immediate-early
genes (IEGs) that encode sequence-specific transcription factors (TFs), including FOS and the neuronal-specific
TF NPAS4. These IEG-encoded TFs (IEG TFs), in turn, induce the expression of diverse cell-type-specific lateresponse gene programs that encode neuropeptides and other secreted factors that regulate circuit plasticity,
and are tailored to the functions of each neuronal subtype. While the induction of FOS has been routinely
employed as a proxy marker of activated neurons, whether FOS is a marker or a mediator of synaptic plasticity
has only recently been addressed, and many questions regarding IEG TF regulation and function in the brain
remain unanswered. In this application we propose to use advanced genetic, biochemical, transcriptomic and
epigenomic, electrophysiological, and behavioral approaches to further probe the regulation and function of
activity-induced TFs and their downstream genomic targets during neuronal maturation and plasticity. Building
upon our prior advances, our goals under the auspices of this R35 proposal are: 1) to determine how distinct
IEG TFs contribute mechanistically to different aspects of activity-induced gene regulation; 2) to elucidate the
roles of IEG TFs in sensory-mediated circuit reorganization; 3) to determine how a common set of IEG TFs
regulate context-specific late-response gene programs; 4) to determine how specific IEG TF target genes
contribute to activity-dependent circuit plasticity; 5) to test the role of IEG TFs in stable neuronal ensemble
formation that underlies learning, memory, and behavior; and 6) to train and mentor the next generation of
neuroscientists, with an emphasis on rigor, creativity, collaboration, diversity, and inclusion. These advances will
reveal mechanisms underlying key aspects of sensory experience-dependent circuit maturation and refinement,
provide insight into how dysregulation of these mechanisms contributes to human neurodevelopmental and
neuropsychiatric disorders, and help to train and prepare the neuroscientists of the future.

Public health relevance
Project Narrative: Sensory input sculpts the developing and mature nervous system in part via the induction of new gene transcription. We are using a combination of genetic, biochemical, transcriptomic, and behavioral approaches to elucidate the contribution of these mechanisms to neural plasticity at the molecular, cellular, and electrophysiological levels. We also aim to understand how the dysfunction of these regulatory mechanisms contributes to human neurodevelopmental conditions and disorders of cognitive function.